EFFECT OF TEGRETOL ON SERUM LIPOPROTEINS AND APOLIPOPROTEINS IN CHILDREN

This protocol was performed to determine the effect of tegretol on lipoprotein metabolism. More specifically, in the past investigators have shown that tegretol may increase HDL-cholesterol and/or LDL-cholesterol. For this study, we measured serum lipoproteins before and 3 months after starting tegretol. The patient population chosen was children between the age of two and ten with a newly diagnosed seizure disorder who would be treated with tegretol.